Attenuating Inflammation to Restore GI Tract Integrity and Reduce Viral Reservoirs During cART

PROJECT SUMMARY
Despite advances in combination antiretroviral therapy (cART), human immunodeficiency virus (HIV) infection
remains a major public health burden. Current therapeutic regimens often achieve complete viral suppression
but require lifelong adherence, as the virus quickly rebounds from tissue and cellular reservoirs following
treatment interruption. Moreover, chronic inflammation persists in cART-suppressed individuals and
contributes to comorbidities even in the absence of detectable viremia. Thus, a major goal in HIV research is
focused on approaches that lead to either sustained viral control or elimination of viral reservoirs (either a
`functional' or `sterilizing' cure), with the additional objective to develop approaches that reduce the persistent
inflammatory process that complicates disease-free remission during cART treatment.
Recent work has highlighted the critical role of the gastrointestinal (GI) tract in HIV persistence, with the GI
tract comprising the vast majority of viral reservoirs in the body during cART. Importantly, residual systemic
inflammation observed in HIV infected, cART suppressed individuals appears driven by increased GI tract
permeability. A substantial body of research has shown a critical role for TNFα in perpetuating the pro-
inflammatory cycle that occurs with other GI disorders, such as inflammatory bowel disease. Notably, TNFα
has been shown to contribute to the pro-inflammatory milieu that is elevated in HIV infected individuals, but the
role of TNFα in GI-associated pathology during HIV disease is not well understood. We hypothesize that
persistent damage to the GI tract epithelial barrier is a major cause of residual local and systemic
inflammation in HIV infected individuals on cART, which plays an important role in viral reservoir
persistence within the GI tract, and attenuating GI tract, and systemic, inflammation will lead to
restored gut restoration, immune homeostasis and reduced reservoir persistence.
TNFα therefore represents an attractive target for mitigating the inflammatory milieu during the chronic
phase of HIV infection. Thus, two different approaches to target TNFα will be utilized in a non-human primate
model of HIV infection, i) an FDA-approved antibody against TNFα therapy (adalimumab, Humira) and ii) a
novel small molecule inhibitor of the downstream kinase, RIPK1. The extent and characteristics of GI tract
pathology and the restoration of immune homeostasis (Aim 1) and the quantity, distribution, and characteristics
of the viral reservoir within the GI tract (Aim 2) will be evaluated throughout treatment and following the
conclusion of the experiments. Discovering a critical role for TNFα in modulating the GI manifestations of HIV
would have a significant impact on the direction of future HIV research and treatment. Moreover, use of either
a novel inhibitor that is currently in clinical development, or the re-purposing of an FDA-approved drug, as new
therapeutic modalities for HIV infection represent a marked innovation in the search for a cure.

Public health relevance
PROJECT NARRATIVE Current combination antiretroviral therapy (cART) allows individuals infected with human immunodeficiency virus (HIV) to achieve viral suppression; however, debilitating comorbidities frequently occur due to residual chronic inflammation, and the presence of viral reservoirs necessitates lifelong adherence to treatment. Using a simian immunodeficiency virus (SIV) infected non-human primate (NHP) model, our proposed studies will determine if blocking the pro-inflammatory TNFα signaling pathway during cART treatment results in restoration of the GI tract epithelial barrier and immune reconstitution, as well as determine the role of inflammation in contributing to reservoir persistence. Towards that end, we will validate both an FDA-approved biologic, which is efficacious in treating inflammatory bowel disease, and a novel small molecule inhibitor in our model system, with the goal of developing an innovative adjunctive therapeutic intervention approach that can be translated into the clinic.